GLUCAGON-LIKE PEPTIDE--REGULATION OF INSULIN ACTION AT EXTRAPANCREATIC SITES

Non-insulin-dependent diabetes mellitus (NIDDM, type II diabetes) is one of the most common diseases in the elderly population of the USA, and is especially common in minority populations. The hyperglycemia is caused by 1) impaired insulin secretion from islets of Langerhans in the pancreas, and 2) impaired sensitivity of peripheral tissues (such as muscle, fat, and liver) to insulin. A promising new approach for treatment of NIDDM is the use of incretin hormones such as glucagon-like peptide (GLP-1). Incretins have many desirable effects which may help NIDDM patients. Incretins stimulate insulin secretion and inhibit glucagon secretion. In addition we have found that GLP-1 stimulates insulin action at insulin sensitive target tissues. Our data have shown that, glucose uptake and lipid synthesis in cultured adipocytes are stimulated by GLP-1 and GLP-1 stimulates glucose oxidation and glycogen synthesis in rat myotubes in culture. Our data also suggest the presence of different GLP receptor isoforms in pancreas versus extrapancreatic tissues. We have evidence that GLP receptor signaling cascade acts differently in pancreas versus extrapancreatic tissues. Further, different agonist specificity for GLP analogs are noted in pancreas versus extrapancreatic tissues. This suggests the exciting possibility to activate selectively GLP receptor isoforms in different tissues in NIDDM therapy. Our goal is to devote effort to molecular cloning of GLP receptor isoforms and to further study in vivo the effects of various GLP-1 analogs in extrapancreatic tissues.